QUANTITATIVE ASPECT OF 5-OXOPROLINE (OP) METABOLISM--HEALTHY VS BURNED PATIENTS

To develop a non-invasive stable isotope tracer method to determine the kinetics of oxo-proline (OP), a substrate closely related to glutathione synthesis, and use OP kinetics as an indicator for the capacity of glutathione synthesis and the status of glutathione within the body of burn subjects and healthy controls.